The role of kynurenine pathway metabolism in pulmonary arterial hypertension

Project Summary/Abstract
Pulmonary arterial hypertension (PAH) is characterized by pulmonary vascular remodeling and increased
pulmonary vascular resistance. Most therapies for PAH work by reducing pulmonary vascular resistance, without
addressing the underlying cellular and molecular mechanisms driving pathobiology. Our prior work in
metabolomics has implicated upregulated kynurenine pathway (KP) metabolism as an early, persistent, and
potentially causal feature contributing to PAH pathobiology. Our preliminary data suggest upregulation of
tryptophan 2,3 dioxygenase (TDO), an enzyme that converts tryptophan to kynurenine, occurs in an expanded
fibroblast population in the PAH lung, and increased TDO drives increased kynurenine production in PAH.
Kynurenine is an endogenous activator of the transcription factor (TF) AHR (aryl hydrocarbon receptor) in other
biologic contexts. Separately, exogenous AHR activation was recently proven necessary and sufficient for PAH
development in a preclinical model, and AHR activity is increased in human PAH. However, the downstream
effects of upregulated KP metabolism in PAH are undefined, and the endogenous upstream activator(s) of AHR
TF activity in human PAH are unknown. We hypothesize that TDO-derived kynurenine is the endogenous
activator of AHR in human PAH, and that kynurenine-induced AHR activity in PAH promotes transcriptional
programs that contribute to pulmonary vascular remodeling and resistance. Because pharmacologic TDO
inhibitors are under study for other applications, interrogation of a TDO-kynurenine-AHR axis may reveal an
opportunity for repurposing of a therapy to PAH that addresses fundamental pathobiology. We propose 3 Specific
Aims. Aim 1 establishes a prospective observational cohort of PAH patients in which we will measure longitudinal
KP metabolites and AHR activity over the treatment course. We will apply a causal inference framework to test
AHR activity as the causal mediator of KP metabolite effects on pulmonary vascular resistance and clinical
outcomes. In Aim 2, we will perform single-cell RNA sequencing in archived PAH lung specimens to investigate
the TDO-expressing fibroblast population using high-resolution clustering, co-expression analyses, and
trajectory inference. We will perform cell-cell ligand-receptor signaling and TF activity analysis on high-resolution
clusters to identify activators of AHR-mediated transcriptional programs. Our proposed use of archived tissues
presents a unique opportunity to analyze KP-AHR cell type-specific transcriptional associations with pulmonary
vascular resistance and other patient-level clinical data. In Aim 3, we will perform complementary gain- and loss-
of-function experiments in rodent models of PAH to examine effects of TDO forced overexpression and inhibition
on KP metabolism and AHR-mediated gene expression in isolated pulmonary vascular cells (e.g., fibroblasts
and endothelial cells) in vitro. Further, we will test the molecular and phenotypic effects of TDO inhibition in our
animal models in vivo. Should our overall hypothesis be confirmed, the proposed studies will provide a robust
evidentiary foundation for early-phase trials investigating KP inhibition as a disease-modifying strategy in PAH.

Public health relevance
Project Narrative Pulmonary arterial hypertension (PAH) remains a significant public health concern due to high mortality rates and limited treatment options. This project investigates the role of kynurenine pathway (KP) upregulation in PAH development in order to identify more specific and effective therapeutic targets. Because drugs that inhibit the rate-limiting step of KP upregulation have already been developed for other applications, this project may enable novel repurposing of existing drugs, thereby improving PAH outcomes and reducing the disease's burden on public health.